Center for Demography of Health and Aging

DESCRIPTION (provided by applicant): This is a proposal for continuing support of the Center for Demography of Health and Aging at the University of Wisconsin-Madison. The overall goal of the Center for Demography of Health and Aging is to sustain and improve a major research and training program in the demography of health and aging. The institutional architecture of CDHA is designed to create links between social demography and biomedical and epidemiological research on health and aging. Major themes of ongoing and developmental research activities within CDHA include (1) Early and Mid-Life Determinants of Late-Life Health and Well-Being;(2) Race, Ethnicity and Socioeconomic Status;(3) Demography of Aging;(4) Trends in Chronic Disease and Disability, and Burden of Illness;and (5) Health, Work and Retirement. During its first decade, CDHA has grown from 39 to 63 faculty members;has successfully turned pilot projects into grants;has grown from about $3.3 million to $74 million in NIA support;has created unique data resources and a secure data enclave;and has substantially expanded training activities. CDHA coexists with the Center for Demography and Ecology and thus shares and extends a well-developed research infrastructure in administration, computing, print library, data library, and GIS facilities. CDHA's administrative core (A) will provide leadership and administrative support for the Center. The program development core (B) will support faculty, staff, and research assistants engaged in innovative pilot research projects that are likely to lead to major NIA support. The external innovative network core (C) will continue a popular, networked current awareness service for research in the demography of aging and support regular workshops, conferences, and visits. The external research resources core (D) will support user-friendly provision of large-scale public data resources in the demography of health and aging. The statistical data enclave core (E) will continue to develop facilities for the analysis of sensitive data under secure conditions. PUBLIC HEALTH RELEVANCE: The challenges of individual aging creates an unending stream of questions that biosocial research may address;population aging magnifies these issues as they affect social organization, health services, and macro-economic change. The Center for Demography of Health and Aging will help to address these challenges as an innovative and flexible provider of research collaboration, training, and infrastructure.

Public health relevance
The challenges of individual aging creates an unending stream of questions that biosocial research may address; population aging magnifies these issues as they affect social organization, health services, and macro-economic change. The Center for Demography of Health and Aging will help to address these challenges as an innovative and flexible provider of research collaboration, training, and infrastructure.